DEAFFERENTATION EFFECTS ON SOMATOSENSORY FUNCTION

The hypothesis that phantom limb results from the reorganization of central neural structures will be evaluated. The investigators will examine whether somatosensory perception is altered following deafferentation.